Mapping the cosmetic chemical exposome and its role in female fertility

PROJECT SUMMARY/ABSTRACT
Infertility affects about 15% of couples. Ovulatory dysfunction is a primary cause with unclear etiology. Studies
have found that certain chemicals are reproductive toxicants and impair female fertility. However, these studies
are limited to a small number of known environmental chemicals, and there are major gaps in understanding of
the impacts of simultaneous exposures to thousands of chemicals (i.e., the exposome) on ovarian function and
female fertility. Thus, there is a critical need to evaluate how complex chemical exposures target reproductive
organs, to determine potential biologic pathways of action, and to identify important sources of exposures and
their racial/ethnic disparities to inform opportunities for intervention. Research Aims: The proposed research
leverages an exposomics approach to evaluate associations between personal care product (PCP) use,
chemical exposure biomarkers, ovarian health biomarkers, and female fertility outcomes. Untargeted high-
resolution mass spectrometry will measure up to 100,000 chemicals and endogenous metabolites in samples
of blood or follicular fluid surrounding developing oocytes. Aim 1 will use machine learning to develop a
generalizable database of signatures in the blood exposome that identify PCP habits, based on 4,188 women
in the Sister Study. This will create a key resource for other ‘omics health studies to retrospectively assess
PCP exposures in banked biologic samples. The PCP signatures can also be used to underpin interpretations
of the chemical exposome in Aims 2 and 3. Aim 2 will evaluate associations between the chemical exposome
in follicular fluid and fertility (e.g., oocyte yield, clinical pregnancy, and live birth) among 70 women undergoing
assisted reproduction technology (ART) from the EMPOWR cohort in Atlanta. Follicular fluid metabolomics will
provide mechanistic insights into biologic pathways underlying associations between exposure and outcome.
With the racial/ethnic diversity of the cohorts in Aims 1–2, we will also investigate disparities in exposure, PCP
signatures, and fertility. Aim 3 will leverage a third cohort of ~250 women in the EARTH study undergoing ART
in Massachusetts and will determine associations of PCP habits and the blood and follicular fluid exposomes
with fertility, while also providing an independent cohort for evaluating shared biological effects identified in Aim
2. Career Goals: Dr. Anna Young’s background includes strong, cross-disciplinary training in environmental
epidemiology, chemical exposure assessment, and computer science. This K99/R00 award will provide critical
development of expertise in exposomics, applied data science, and reproductive epidemiology to position her
for a high-impact independent research career studying the impact of the exposome on understudied female
reproductive disorders. Dr. Young’s training will consist of courses, conferences, seminars, and hands-on
mentoring from an exceptional multi-disciplinary team: Drs. Douglas Walker (primary mentor), Audrey Gaskins
(co-mentor), Russ Hauser, Chris Gennings, Shruthi Mahalingaiah, Alexandra White, and Christine Ekenga.

Public health relevance
PROJECT NARRATIVE Endocrine-disrupting chemicals have been identified as potential ovarian toxicants and linked to impaired fertility, which is a common issue experienced by ~15% of couples. The proposed research will advance systematic exposome approaches to investigate how complex exposures to thousands of chemicals impact ovarian health and female fertility. This research will also evaluate personal care product habits and their associated racial/ethnic disparities as potential sources to inform future exposure reduction interventions.